Epigenetic Marks of Cocaine Addiction

Project Summary Multiple interacting genes and environmental factors determine the risk and trajectory of drug addiction. Expression of genes involved in the risk and consequences of addiction is influenced by environmental factors that in many cases are likely to leave persistent chemical modifications (epigenetic marks) in DNA and chromatin. We propose to comprehensively identify in archived postmortem human brain, changes in gene expression and linked epigenetic marks associated with chronic cocaine dependence. We will study two dopamine-dependent brain regions, the dorsal and ventral striatum. We will profile epigenetic marks in cocaine abusers with both short and long-term drug exposures. For analysis of the transcriptome, we will perform whole genome, strand- specific sequencing of mRNA transcripts (RNA-seq). For the DNA methylome, we will use MeDIP or equivalent technology to map the distribution of methyl CpG's at genome- wide and locus specific levels. The ultimate aim of this proposal is to discover which epigenetic changes in brain accompany the transition from cocaine abuse to chronic cocaine dependence. Discovery of cocaine-associated networks and pathways will provide clues to the etiology of cocaine addiction and will identify likely points of intervention in molecular and biochemical pathways that represent potential therapeutic targets.

Public health relevance
Project narrative Multiple interacting genes and environmental factors underlie the risk of drug addiction. First-time high throughput technologies will be used to develop epigenome maps of human brain, which are essential for understanding how epigenetic mechanisms figure in the neurobiology of drug abuse. We will profile epigenetic marks in human brain from chronic cocaine abusers to better our understanding and treatment of drug addiction. __SpecificAimsTextDelimiter__ This application seeks to characterize DNA methylation changes that occur in the human brain, and specifically in neurons from the rostral striatum. Major advances during the decade of the brain (1990 - 2000) came from NIDA funded initiatives for noninvasive neuroimaging studies, which made it possible to study neuroanatomical, neurochemical and functional changes in the human brain that contribute to the vulnerability to abuse drugs or are the neurotoxic consequences of years of drug misuse ([1, 2]). Animal models have been developed to explain the fundamental behavioral and biological mechanisms of addiction, including reward, tolerance and dependence ([3, 4]). From these studies, we learned that cocaine abuse not only alters the epigenetic status of genes, but also induces particular epigenetic modifications depending on the frequency of the drug's administration. Certain genes are switched on by infrequent (short-term exposure) administration, while others are switched on only after chronic administration (addiction/dependence). Animal studies have also suggested that cocaine-seeking habits modeling chronic cocaine addiction in humans depend upon dopamine-dependent serial connectivity linking the ventral (nucleus accumbens) with the dorsal striatum (caudate nucleus) ([5]). While much has been learned on epigenetic processes mediating cocaine addiction in animals, there is an absence of information in the human brain. We ignore, for instance, which genes are modified by acute administration of cocaine, and how these changes compare to those that are regulated by chronic drug administration. The primary goal of this proposal is to identify DNA methylation changes that occur in the transition from cocaine use to cocaine addiction. To this end, we propose a series of high throughput sequencing studies investigating unique postmortem human brain specimens from individuals with chronic addiction to cocaine (cocaine dependence), as compared to recreational cocaine users and negative controls. Tissue for the screening and replication samples of this study is available from 2 different brain banks, both of which have phenotypically well-characterized brain tissue. Specifically, we aim to: Aim 1: Conduct MeDIP-Seq in DNA from (i) the nucleus accumbens (NAc) and (ii) from the dorsal striatum (caudate nucleus) of 3 groups of individuals from the Miami Brain Bank: (1a) N = 25 individuals with histories of chronic cocaine dependence, defined as meeting DSM-IV criteria for lifetime cocaine dependence (1b) N = 25 individuals with histories of recreational cocaine use, defined as having negative histories of cocaine dependence or cocaine abuse, but with positive cocaine toxicology in blood at the time of death. (1c) N = 25 age-matched controls with no history of cocaine use disorders, negative cocaine and metabolite toxicology and no history of comorbid psychopathology. Aim 2: Extract, by means of fluorescence activated cell sorting (FACS), neuronal and non-neuronal fractions from samples used in Aim 1 and from a replication sample (Miami and Quebec Brain Banks) to validate and characterize the most significant differentially methylated sequences. (2a) Prioritize regions for bisulfite sequencing validation based on strength of the differential methylation signal and the probability of biological effect on critical pathways or genes based on bioinformatic analyses. (2b) Validate methylation findings of interest in individual sequences using MALDI-TOF mass spectrometry quantification of methylation content (EpiTYPER platform). Aim 3: Profile dynamic CpG sites that are uniquely differentially methylated in the brain of individuals with chronic cocaine dependence. To do so, we will conduct a series of related studies. Namely: (3a) Carry out RNA-Seq from all samples included in the studies listed above in order to assess the functional impact of the differential methylation associated with cocaine abuse. (3b) Assess the sensitivity and specificity of the RNA-seq approach by reverse transcription-PCR and quantitative PCR validation runs for select genes. (3c) Further explore the functional impact of differential methylation associated with cocaine abuse using site directed/patch methylation in cellular assays.